MSKCC Core Site

The MSKCC public website is an important informafion and recruitment tool. It can be accessed by prospective patients and outside providers and indudes descriptions of all AMC trials, a link to the AMC public website, and more general information on HIV-associated malignancies. MSKCC has also been awarded a one-year administrative supplement to our Center's U54 grant to develop, implement, and analyze a community-needs assessment on cancer education, prevention, and control in community-based organizations sen/ing PLWHA, and to identify barriers to timely, culturally sensitive treatment and dinical trials participation. Dr. Jack Burkhalter from Psychiatry leads this effort and Dr. Krown is a Co-lnvestigator. It should help to enhance our recruitment efforts, particulariy among underserved populafions.